Genetic determinants of interbacterial competition during host colonization

Project Summary
The biological functions of microbiomes are critical to human health. Perturbations of these
microbiomes can lead to damaging consequences including improper host development and
increased susceptibility to infectious disease. Competitive interactions among microbial
populations are predicted to influence the structure and function of microbiomes, yet the
molecular mechanisms underlying these interactions remain unclear. Understanding
microbiome dynamics is therefore critical to predicting and mitigating dysbiosis and disease risk
in humans. Type VI secretion systems (T6SSs) are a conserved protein export mechanism
found in both pathogenic and beneficial human-associated bacteria. T6SSs act as molecular
syringes to translocate toxic effector proteins directly into competitor cells, resulting in inhibition
or death. Given their role in interbacterial competition, T6SSs are capable of structuring
microbiome communities within a host-associated niche. The goal of this proposal is to
understand how T6SS-mediated interactions shape host-associated microbiomes. The results
of this work will facilitate the development of strategies to improve host health. Recent findings
using the squid light organ as a model system indicate that bacteria can use their T6SS to
compete for a limited number of colonization sites in the host. The proposed work will determine
the molecular mechanisms underlying T6SS-mediated killing among co-colonizing bacteria, and
determine the spatial and temporal dynamics of these competitive interactions in the host, and
its effect on structuring the resulting microbiome.

Public health relevance
Project Narrative We use a natural host colonization model system to study how competitive interactions between bacterial populations impact which populations can infect and persist inside a host. We found that bacterial colonizers use a type VI secretion system (T6SS) to kill competing strains for access to host colonization sites. We will determine how these bacteria target other cells for killing, as well as the extent to which competition influences the spatial arrangements of members comprising a natural host-associated microbiome.